Mechanisms of Cellular Communication: The Role of Merlin in Pancreatic Development

PROJECT SUMMARY
More than 30 million Americans have pre- or existing diabetes. An innovative approach to treat
diabetes is to generate functional insulin-producing -cells for transplantation in vitro. This approach
is currently in clinical trials, but a recognized problem is suboptimal progenitor generation. -cells
originate from a multipotent progenitor population in the early pancreatic epithelium. Elucidating
mechanisms that regulate progenitor specification and maturation in vivo using mouse models will
instruct in vitro differentiation efforts.
The Hippo pathway is emerging as a key mechanotransducive pathway involved in regulating
organ development, however, mechanisms that regulate Hippo signaling in the context of
pancreatic development remain unclear. This proposal will examine Merlin, a key regulator of
Hippo signaling, to determine if it relays biomechanical signals during tissue morphogenesis. We
have found that deleting Merlin leads to severely aberrant pancreatic morphogenesis and cell
differentiation. Currently, we aim to elucidate both how Merlin is regulated and what its molecular
function is in pancreatic development.
The central hypothesis of this proposal is that Merlin
enables pancreatic lumenogenesis by interpreting cues from cytoskeletal contractility to
organize the apical membrane.
In Aim 1, I will examine if Merlin directs pancreas formation non-
cell autonomously in vivo by using mouse genetics and in vitro by using a 3-D spheroid model.
Using a mosaic deletion system, I will assess if Merlin is required for propagation of tension-based
cues. In Aim 2, I will determine the cellular function of Merlin; specifically, I will determine if Merlin
facilities vesicular trafficking events required for lumenogenesis by using a novel live imaging
system that our lab developed. In Aim 3, I will examine if mechanical cues regulate Merlin
phosphorylation status and function in a 2D cell culture, through direct application of tension using
cell stretching system. I will further determine if Merlin phosphorylation is required for YAP1/TAZ
inhibition. Together, this data will provide us with insight into how mechanical cues guide
pancreatic morphogenesis and cell fate. More broadly, our results will shed light on how progenitor
specification and maturation occur and will guide regenerative medicine efforts.

Public health relevance
Progenitor, or stem cells, that give rise to insulin-producing islet cells emerge from embryonic endodermal epithelium within the early pancreatic bud. This work focuses on the basic molecular mechanisms that shape the cellular microenvironment and 3D epithelial architecture where pancreatic endocrine cells are born. Understanding these basic processes will lead to novel insights into regenerative and replacement therapies for diabetes mellitus.